Understanding Geometric and Electronic Structure Contributions to Ground and Excited State Cu- and Ni-Catalyzed Cross-Coupling Reactions

Project Summary
Developing sustainable approaches to the synthesis of molecular therapeutics will be important for the
continued evolution and success of medicinal and pharmaceutical chemistries. A major component of
drug synthesis involves transition metal catalyzed C–X (X = C, N, O, etc.) bond formation reactions.
While precious metals such as Pd are used for these reactions, first row transition metals are becoming
more widely adopted, as they are abundant and open new mechanistic pathways involving one- and
multi-electron transfer reactivity, which can potentially work in concert with ligand noninnocence and
multireference electronic structure to form transformative structure/function relationships. The merger
of thermal catalysis with photochemistry also provides new mechanistic possibilities for cross-couplings
that harness the energy of light to drive bond-formation reactions that would not occur in ground states.
However, the nature of inorganic intermediates and the important ultrafast transition metal excited state
relaxation processes in ground and excited state cross-coupling reactions are not well understood. This
proposal therefore applies physical inorganic approaches to develop a fundamental knowledge base
of the geometric and electronic structures of the critical inorganic species formed in Cu- and Ni-
catalyzed cross-coupling reactions, as well as the time and energy evolution of photoinduced electronic
states involved in excited state catalysis. This knowledge base will ultimately guide the development of
a molecular engineering approach to ligand development and catalyst discovery. We will bring new
spectroscopic methods to the field, including variable temperature variable field magnetic circular
dichroism (VTVH MCD) and X-ray absorption and emission spectroscopies, which will be critical to
quantitatively define transition metal electronic structure, including multireference character. Ultrafast
optical and X-ray spectroscopic approaches will also be used to define the key photonic energy
distribution pathways that define photocatalyst efficiency and further guide ligand perturbations to
control the excited state potential energy surfaces (PESs) of photocatalysts. Spectral features of
isolable species will be used to experimentally calibrate computational methods to define the critical
frontier molecular orbitals and bonding interactions that activate metal centers for reactivity, especially
those that are fleeting but critical to catalysis. Electronic structure calculations will also allow for the
translation of our understanding of resting states, intermediates, and excited states to reaction
coordinates in catalysis and the PESs governing relaxation pathways. In concert with collaborative
methodological studies, the proposed research will help inform chemists how to leverage the ground
and excited state electronic structures of first-row transition metal complexes and thus guide academic
and industry research toward sustainable approaches for bond constructions in drug synthesis.

Public health relevance
Project Narrative Cross-coupling reactions enable the construction of new C–X bonds (X = C, N, O, F, etc.) necessary for the synthesis of existing pharmaceuticals and new drug candidates. While precious metal Pd-based catalysts are largely used on an industrial scale, the combination of the disparate electron transfer properties of earth abundant first row transition metal catalysts and the possibility of harnessing light energy to generate uniquely reactive electronic states represents an attractive, sustainable approach to accessing new mechanistic possibilities for drug synthesis and discovery. Using a combined spectroscopic and computational approach, the objective of this proposal is to define the critical electronic structure contributions to ground state Cu- and Ni-catalyzed cross-couplings and to further use and develop time-resolved spectroscopies to elucidate key excited state factors that allow for sustainable light-driven syntheses of molecular therapeutics.